Father Closeness in Early Childhood as Predictor of Adult Health Outcomes

PROJECT SUMMARY
The Pathways to Health (PaTH) parent project (R01HL152444, PI’s: Marlsand/Shaw), designed
to identify factors that contribute to emerging cardiometabolic health disparities that track a
socioeconomic gradient, will investigate family-, school-, and community-level factors during
critical periods of childhood that are expected to mediate associations between low family
income and cardiometabolic health in 248 adult men (aged 31-33 years). While the onset of
cardiovascular disease typically occurs in adulthood, the pathogenesis of cardiovascular disease
begins in childhood. The quality of parent-child relationships has been consistently cited as a
major contributor to the early emergence of risky health factors and behaviors, yet most of this
research focuses exclusively on mother-child relationships or mother- and father- child
relationships assessed jointly. As the number of children living with two biological, married
parents has declined and family instability has become increasingly prevalent, it is imperative to
examine the father-child relationship independently and to consider the context of father-child
coresidence to better understand which pathways, and for whom, father-child relationships affect
physical health. As a logical extension of the parent project, we propose to use this diversity
supplement and training experience to allow a promising minority predoctoral student to
examine whether father-son relationship closeness/conflict during early childhood is associated
with differences in combined indices of cardiometabolic health risk (e.g., elevated blood
pressure, obesity, systemic inflammation) and health behaviors (e.g., sleep quality, substance
use) at age 31 and to test whether this association is moderated by father-child coresidence and
mediated by adolescent markers of health risk.

Public health relevance
PROJECT NARRATIVE Although the quality of parent-child relationships has been consistently cited as a major contributor to dimensions of health, including adult inflammation, most of this research has focused exclusively on mother-child relationships or mother- and father- child relationships assessed jointly. It has been suggested that the father-child relationship contributes independent and enduring effects on physiological stress response and engagement in health-risking coping behaviors. Because the presence of such risky health factors and behaviors promote chronic inflammatory responses, another established risk factor for adult cardiovascular disease, we seek to examine the contributions of the early father-child relationship to young adult physical health and cardiovascular risk and to test whether this association is moderated by father-child coresidence and mediated by adolescent markers of health risk.